REDUCING BLOOD DONOR EXPOSURE IN VLBW INFANTS

Preterm infants with birth weight less than 1250g will be studied to determine whether treatment with recombinant human erythropoietin (EPO), beginning in the first 4 days of life and continuing through discharge or 35 weeks post conceptional age, can: reduce the number of transfusion- related donor exposures and the number of transfusions; and increase the number of non-transfused infants that occur when dedicated units of red blood cells and transfusion guidelines are used in comparison to infants who are not treated with EPO. (This is a NICHD Neonatal Research Network Trial.)